Antibody induced T cell mediated neonatal autoimmunity

Our recent studies on autoJmmune ovarian disease (AOD) have accrued evidence that stimulation by antigen and environmental factor early in life predisposes genetically-susceptible mice to early- and late-onset autoimmune disease, and this is explicable by the relative paucity of the CD4+CD2.5+ regulatory T cells present early in life. We have now made a new and striking observation that further strengthens the paradigm. Autoantibody (autoAb) to the ovarian zona pellncida 3 (ZP3) B cell epitope (335-342) was found to preferentially injure ovaries in neonatal mice while sparing ovaries of adult mice. Interestingly, although the ovarian disease is triggered by ZP3 autoAb, disease expression depends on the presence of T cells in the neonate, and is associated with de nero neonatal autoimmane T cell response to ovarian antigen. In addition, induction of this neonatal AOD is B cell epitope-specific; thus autoAb to a second ZP3 native B cell epitope (171-180) is non-pathogenic. Even more exciting, neonatal AOD develops only when the autoAb first reaches the neonatal mice in the first 5 days of life. Theorem, maternal autoAb can trigger in neonates pathogenic autoi_une T [unreadable][unreadable]11_sponse and neonatal AOD; the di_ _duction i_ B cell epito_snecific, and only imvacts neonatal mi_ _t are known to be defi[unreadable]i_ in _gulato_ T cells. We now propose the following experimental approaches to further investigate these new and exciting observations. H_ we will test the hypothesis that neonatal AOD is triggered by epitope-specific autoAb, which forms immune complexes with endogenous Ag, to induce ZP3 specific pathogenic T celt response and tong-term autoimmune memory. Second, we will test the hypothesis that activation of antigen presenting cells by immune complex is dependent on their Fc receptor, and this event is required for neonatal AOD induction. Third, we will test the hypothesis that CD4+ CD25+ regulatory T cell deficiency in neonatal mice explains the propensity of neonatal mice to develop autoimmune response and disease. This proposal will therefore address fundamental mechanisms responsible for autoimmune induction and prevention, and specifically, neonatal autoimmane diseases including systemic lupus-related congenital heart block. PERFORCE Si_(S) (organizatiocnit,y,state) Universityof Virginia CiaariottesvilteV, irginia KEY PERSONNEL, See tnstruotions, Use cont/nuat/onpages as neededto provide the requited information in the format shown below. Start with Principal Investigator, List all other key personnel inalphabette,al order, tast name first, Name Organization Role on Projeot Kenneth S,K. Tung, M.D. Universityof Virginia PrincipalInvestigator Yulius Sctiady, Ph.D. University of Virginia Co- Principal Investigator Eilccn Samy, MS Universityof Virginia Co- investigator __$t_t_/Nmt. _icabtetoS_R/STTR Orgy. See_. [:]Villi [_No - PHS 398 (Roy. 05/01) Page _ Form Page2 o o P_paJ Jnves_gator/ProgrDamJr_k_(rLast,firstm, _e): Tung, Kenneth S.K. The name of the principalinvestigator/progrsm directormust be provided at the top of each printed page and each continuationpage. RESEARCH GRANT TABLE OF CONTENTS Page Nurnbet_ Face Page .................................................................................................................................................. 1 Description,